COMPARISON OF REPAGLINIDE AND GLYBURIDE FOR THE TREATMENT OF TYPE II DM

This is a multi-center study comparing the effects of Repaglinide to Glyburide in the treatment of Type II Diabetes Mellitus (DM).